Nonreceptor tyrosine kinases in Systemic Lupus Erythematosus

Tyrosine kinases are important regulators of growth, differentiation, and apoptosis in eukaryotic cells.
Inappropriate tyrosine kinase signaling is observed in many cancers and inflammatory diseases. This
project focuses on the structure, activity, and regulation of the Ack1 and Brk nonreceptor tyrosine kinases.
In collaboration with Dr. Frederic Geissmann and colleagues, we have discovered a series of loss-of-
function mutations in Ack1 and Brk in a cohort of patients with severe Systemic Lupus Erythematosus
(SLE). These are the first tyrosine kinase mutations found to be linked to this disease. Our preliminary work
shows that the mutations drastically decrease (or completely block) kinase activity, downstream signaling,
and phagocytosis of apoptotic cells. We propose to conduct functional studies of the wild-type and mutant
forms of Ack1 and Brk in mammalian cells, including experiments in induced pluripotent stem cell (iPSC)-
derived macrophages from the lupus patients and their healthy relatives. We will carry out global screens of
substrate specificity to determine whether the mutations “rewire” cellular signaling networks. We will also
carry out mechanistic and structural studies on the purified mutant kinases, and test how they are coupled
to the cell surface receptor MerTK. The overall hypothesis is that Ack1 and Brk link recognition of
phosphatidylserine on apoptotic cells to phagocytic engulfment. Regulation or tuning of this signaling
pathway could provide a new strategy for therapeutic approaches in autoimmune diseases.

Public health relevance
W. Todd Miller Project Narrative This project examines a novel series of mutations in cellular enzymes that are found in patients with severe lupus. The proposed work will shed light on the activity and substrate specificity of these enzymes in normal physiology, and may provide new strategies to modulate these pathways in human disease.